From Data to Action: Capturing Meaningful Outcomes in Autism Through Harmonized Data

ABSTRACT
There are more autistic adults in the service system than ever before, and this number is estimated to
increase by as much as 300% by 2030. Outcomes for autistic adults are often characterized by low rates
of employment and community participation, and high rates of anxiety, depression, and suicidality. Our
community partners, including autistic adults and caregivers, have identified the need for research across
the adult lifespan that identifies intervention and service targets to promote a high quality of life
characterized by good mental health and community participation. We believe that generating a better
understanding of autistic adults, including those in mid- and later life, is a pressing public health problem
where rapid advancements are needed. To date, however, the field of adult autism research has primarily
relied on small, non-representative samples limited to young adulthood. This has hindered our ability to
understand outcomes and identify service targets across the adult lifespan and the full autism spectrum
(i.e., inclusive of those with and without intellectual disability and a variety of levels of support needs).
In response to ROA-OTA-25-006, we leverage an unprecedented collaboration between senior
researchers across 4 NIH Autism Center of Excellence (ACE) sites focused on autistic adults. We employ
a data driven approach to characterize service needs and targets in cross-sectional and longitudinal
samples of autistic adults representative of the full adult lifespan and the full autism spectrum. We will
deploy two complementary datasets that are optimally poised to make rapid advancements in service
access, NIMH Data Archive (NDA) and Simons Powering Autism Research (SPARK). The NDA data
collected across ACE projects provides one of the largest samples of well-characterized autistic adults
(n=1,400). The SPARK dataset represents one of the largest longitudinal samples (n=400) of autistic
adults. This proposal has three tasks:
(I) Dataset Aggregation from the NDA to harmonize the parallel assessment protocol developed by the
study team and utilized across 4 ACE sites to identify modifiable adult outcomes.
(II) Data Generation to 1) generate geocodes to examine the influence of environmental and
neighborhood factors (e.g., socioeconomic factors, provider density, environmental exposures) on
service use and needs and trajectories of change in adult outcomes and 2) collect a third time point
of data in a longitudinal cohort of 400 autistic adults from SPARK to examine trajectories of change
in these modifiable outcomes across adulthood. This additional data collection will complement our
aggregated NDA data by advancing our ability to answer questions about drivers of service needs
measured over time across the entirety of the dynamic adult years.
(III) Data Analyses using both machine learning and (longitudinal) latent transition analyses. We will use
machine learning to identify subgroups in the NDA dataset based on their differing profiles of service
use and needs and predict subgroup membership based on service targets and sociodemographic
indicators. This will allow us to examine specific hypotheses focused on identifying the greatest
service needs in this population, the relation between service needs and service targets to improve
adult outcomes (mental health, community participation, quality of life). We will use latent transition
analysis in the SPARK dataset to identify drivers of service use and needs based on trajectories of
change across time. This will allow us to identify longitudinal trajectories of adult outcomes and their
relation to service needs.
Our work will be conducted in partnership with a 20-member Community Advisory Board (CAB) that
includes autistic adults, family members/caregivers, researchers, clinicians and service providers for
autistic adults, and state services representatives. The CAB will identify community-driven priorities for
analysis. It will also provide interpretation of findings that will inform innovative, implementation-ready
approaches to enhance meaningful outcomes for autistic adults. The intensive exchange of knowledge
between the CAB and the data science team will produce a team of autistic community research partners
experienced in collaboration with potential for major contributions to public service well beyond this grant.
This OTA directly addresses the Autism Data Science Initiative goals by using multiple data sources to
characterize service utilization patterns and pinpoint potential service targets that will lead to effective and
scalable interventions across the lifespan. This work will advance our understanding of adulthood and
aging in autistic people and accelerate community-informed, efficient, and effective policy and program
priorities that address service access to improve quality of life, increase community participation, and
reduce co-occurring mental health challenges.